Polymer-derived biomaterials for mRNA delivery to induce antigen-specific immune tolerance

Project Summary
The immune system protects people from pathogens. However, it sometimes generates abnormal immune
reactions against harmless environmental antigens or patient’s own antigens, leading to allergy or autoimmune
diseases, respectively. These hypersensitivity disorders affect millions of Americans and are life-threatening in
severe conditions. Current therapeutic strategies often require lifelong treatment and/or broad
immunosuppression, causing adverse effects. The induction of antigen-specific immune tolerance is a promising
strategy to treat hypersensitivity without compromising immune protection because this strategy either
specifically eliminate the disease-related immune cells or restrains their hypersensitive response, leaving the
immune system intact. The tolerance may last lifelong once established. Although progress has been made in
this area, technologies that induce efficient antigen-specific immune tolerance remain to be developed. The key
to success in tolerance induction is the precise modulation of targeted immune cells. Compared to small drug
molecules, a set of proteins translated from delivered messenger RNAs (mRNAs) in immune cells can work
coordinately to transform the cells in a more precise manner. The success of COVID-19 mRNA vaccines has
validated mRNA delivery as a platform for antigen-specific immune stimulation. However, mRNA delivery for
inducing immune tolerance, an opposite effect as immune stimulation, has not been established. This is because
most reported mRNA delivery nanocarriers cause inflammatory response and/or cannot target the right antigen-
presenting cells (APCs) to initiate the process of tolerance induction. We have recently shown that our polymeric
nanoparticle could efficiently target liver sinusoidal endothelial cells (LSECs), which are a type of APCs naturally
helping the immune system maintain tolerance. We hypothesize that nanocarriers derived from this polymeric
nanoparticle can co-deliver antigens and mRNAs encoding tolerogenic proteins to LSECs to induce antigen-
specific immune tolerance. In our preliminary study, we demonstrated that such a nanocarrier can deliver mRNA
to LSECs in mice for protein translation after systemic administration. We also demonstrated that the nanocarrier
loaded with an antigen can inhibit the antigen-specific T cells from being restimulated after in vivo treatment of
mice. We will test our hypothesis by 1) evaluating diverse nanocarrier formulations encapsulating antigen and
mRNA in vitro; 2) investigating the biodistribution of selected nanocarriers and their tolerogenic potential in vivo;
3) demonstrating nanocarrier efficacy in animal disease models and elucidating the mechanism. Our proposed
study is expected to have a broad scientific and societal impact by achieving antigen-specific tolerance via mRNA
delivery.

Public health relevance
Project Narrative Hypersensitivity is an abnormal immune reaction to environmental or patient’s own antigens and causes allergy or autoimmune diseases, affecting millions of Americans with a broad spectrum of unmet medical needs. This proposed research aims to develop a novel nanocarrier platform to co-deliver disease-related antigens and mRNAs encoding tolerogenic cytokines to the liver antigen-presenting cells for inducing antigen-specific immune tolerance. Our proposed study may have both scientific and societal impacts by achieving antigen-specific tolerance via mRNA-based precise modulation of immune cells in the therapy of hypersensitivity.